Discovery of novel lead-target pairs and identification of all-oral bactericidal drug regimens for Mycobacterium abscessus lung disease

ABSTRACT
Mycobacterium abscessus (Mab) accounts for most pulmonary infections caused by fast-growing non-
tuberculous mycobacteria (NTM). Incidence and prevalence rates are increasing throughout the developed
world, there is currently no reliable cure for Mab lung disease, and the drug development pipeline is limited to
repurposed and largely underperforming antibiotics. During the previous funding cycle, we have leveraged 2
decades of chemical matter, tools and concepts developed by the TB community to build an attractive anti-Mab
drug discovery portfolio of 8 novel advanced lead compounds with demonstrated efficacy in an
immunocompromised Mab mouse model. Meanwhile, we have optimized an immune-competent model with
separately acquired funds to address the caveats of immunodeficiency. We have also uncovered the intrinsic
mechanism by which Mab resists rifamycins and used this knowledge to synthesize 20- to 100-fold more potent
analogs with 50- to 100-fold improved pharmacokinetic-pharmacodynamic parameters. Using targeted drug
combination approaches, we have uncovered outstanding bactericidal synergies between (i) rifabutin,
moxifloxacin and tebipenem, and (ii) amoxicillin and each of sulopenem, tebipenem and cefuroxime, all oral -
lactams that are approved or in late clinical development, acting synergistically due to the combined inhibition of
complementary/redundant peptidoglycan synthesis enzymes. Building on these promising results, the major
goals of this renewal application are (i) to advance promising hits and optimize early leads, (ii) to populate the
Mab preclinical candidate pipeline and (iii) to identify all-oral bactericidal combination regimens ready to enter
clinical trials. Our team of antimycobacterial drug discovery experts in microbiology and pharmacology will
continue to leverage the successful partnerships established with external chemistry collaborators. As in the
previous funding cycle, we will access compound collections and medicinal chemistry support from academic
and Pharma partners, a business model that has proven successful. The hit-to-lead and lead optimization
programs will capitalize on our successes with a novel class of non-fluoroquinolone gyrase inhibitors, rifamycin
and non-rifamycin RNA polymerase inhibitors, to deliver leads and preclinical development candidates with
efficacy in the immuno-compromised and -competent mouse models. To prioritize trial-ready all-oral drug
combinations, we will focus our efforts on the bactericidal 2- and 3-drug backbones and combine these with
bacteriostatic and bactericidal oral drugs used for the treatment of M. abscessus. Combinations that preserve
bactericidal and sterilizing activity of the backbones will be prioritized for testing in both mouse models.
Our unique niche consists in a pragmatic approach focused on compound sets active against TB, novel
ligand/target pairs and late clinical development candidates or approved antibiotics, maximizing both short and
long-term chances of success, to accelerate the discovery of all-oral cures against Mab lung disease.

Public health relevance
NARRATIVE A deadly lung disease caused by Mycobacterium abscessus, a cousin of the bacterium that causes tuberculosis, is becoming more prevalent worldwide, particularly in aging and immunocompromised individuals. Currently available therapies often fail to achieve cure due to the intrinsic resistance of M. abscessus to most approved antibiotics, several of which have serious side effects and must be injected. Here we propose to discover and optimize new medicines and better combine existing ones to improve the treatment of M. abscessus lung disease.